"The Evident FV-4000 Confocal Microscope"

PROJECT SUMMARY
Confocal microscopy is an essential tool in biomedical research, imaging structural and dynamic interactions
within complex biological systems. The nature of confocal microscopy posed several practical limitations in
multiplexing capabilities, imaging volume with sufficient spatial resolution, imaging speed, as well as
postprocessing when image stitching and registration is needed. In addition, time-lapsing imaging in dynamic
processes requires system automation and stability to accommodate with any motion artifacts and focus drift
over time. All these practical limitations, if not addressed adequately, would limit our research capacity. The
acquisition of the Olympus FV4000 confocal microscope provides solutions to all above limitations, enabled by
new generation of silicone photomultiplier (SiPM), high-speed resonance scanner, as well as advanced software
package. In this application, we provided detailed justification and description of the Olympus FV4000 confocal
microscope, description of NIH-funded research projects by the major users, as well as necessary technical and
institutional support to maximize the utility. We also have a well-developed administrative plan in place to
manage the equipment in a shared facility. In summary, the acquisition of Olympus FV4000 confocal microscope
will support a wide range of research topic from large number of research labs in Wilmer Eye Institute and Johns
Hopkins research community and will boost the important research initiatives in Wilmer and JHU.

Public health relevance
PROJECT NARRATIVE This S10 application seeks to acquire an Olympus FV4000 confocal microscope in microscopy core in Wilmer Eye Institute at Johns Hopkins University. The confocal microscope will expand the capacity to accommodate a broad range of research labs with superior imaging speed and quality than its predecessor, and thus enhance research projects supported by NIH.